ACTG 320--INDINAVIR WITH OPEN LABEL ZIDOVUDINE AND LAMIVUDINE

A randomized, double-blind study to determine the efficacy of Indinavir with open-label Zidovudine and Lamivudine in subjects with HIV infection.